Program Development (Pilot) Core

Project Summary
Program Development (Pilot) Core (Core B)
The Program Development (Pilot) Core (Core B) of the Michigan Center on the Demography of
Aging (MiCDA) will enhance research on the demography of aging by providing opportunities for
faculty engagement and career development of early- and mid-career affiliates and funding pilot
projects. Faculty engagement and development will occur through annual MiCDA affiliate
conferences and/or symposia, a MiCDA fellows program, and the opportunity to apply for faculty
development funds to attend conferences, workshops or complete coursework related to the
demography of aging. Pilot projects will highlight MiCDA's three signature themes: (1) Enriching
data infrastructure to advance breakthroughs in the demography of aging; (2) The changing
demography of late-life disability and dementia and related family caregiving issues; (3) Life
course determinants of health and wellbeing in later life and related disparities. Beginning in the
second year, pilot projects will be offered both to MiCDA affiliates and to External Network
members (Core C) to promote cross-rank and cross-institutional collaborations.